Activity-Dependent Transcriptional Pathways Underlying Synaptic Mechanisms for Memory Discrimination and Generalization

PROJECT SUMMARY
The ability of the brain to utilize information from past experiences to guide future decisions, termed adaptive
behavior, is critical for survival. To effectively adapt behaviors, the brain applies stored memory to new but similar
situations (generalization), while also maintaining the capacity to distinguish unique stimuli (discrimination).
When these critical processes (memory generalization or discrimination) go awry, it can lead to maladaptive
disorders such as post-traumatic stress disorder (PTSD) and panic disorder. Despite their importance,
mechanisms underlying memory discrimination and generalization remain largely unknown. This proposal will
investigate the dynamic processes that underlie the utilization of an encoded memory to guide future behaviors,
in particular the molecular, synaptic, and circuit mechanisms that govern the balance between discrimination
and generalization. We have collected very exciting preliminary data showing that individual contextual fear
memories are represented in the dentate gyrus (DG) by multiple functionally distinct neuronal ensembles defined
by different activity-dependent transcriptional pathways, and that these ensembles bi-directionally regulate the
discrimination-generalization balance. Based on these exciting findings, we hypothesize that the activity-
dependent pathways target specific synaptic inputs on DG granule cells to differentially control memory
discrimination and generalization. We aim to (1) uncover novel forms of learning-induced synaptic plasticity; (2)
reveal underlying circuit mechanisms for memory discrimination and generalization; and (3) identify the
molecular players important for this experience-dependent behavioral adaptation. The proposed research is both
conceptually and technically innovative. It will experimentally demonstrate for the first time functionally distinct
active neuronal ensembles coexisting within the memory engram, shed light on the synaptic and circuit
mechanisms by which encoded memories directly drive experience-dependent behavioral outputs, and may lead
to new treatment strategies for neuropsychiatric disorders, such as PTSD and panic disorder, which are caused
by the imbalance between memory discrimination and generalization.

Public health relevance
Significance and Health Relevance of Proposed Studies The research described in this proposal will shed new light on the synaptic and circuit mechanisms underlying memory discrimination and generalization, and may lead to new treatment strategies for neuropsychiatric disorders, such as PTSD and panic disorder, that are caused by the imbalance between memory discrimination and generalization.